Targeting of somatic hypermutation in the genome

-+ 2'! &7.#0+32 2'-, %#,#0 2#1 .-',2 +32 2'-,1 ', '++3,-%*- 3*', % %#,#1 ," '1 4'2 * $-0 2&#
%#,#0 2'-, -$ &'%& $$','27 ,2' -"'#1 4 !!',# #$$'! !7 ," .0-2#!2'-, % ',12 ',$#!2'-, &# 0# !2'-, '1
','2' 2#" 5&#, 2&# !2'4 2'-, ',"3!#" "# +', 1# "# +', 2#1 !72'"',#1 ', 1',%*# 120 ,"#" ', 2&#
!-,2#62 -$ 20 ,1!0'.2'-, 7 .-*7+#0 1# -* '1 2 0%#2',% -$ !-,20' 32#1 2- %#,#2'! ',12 '*'27
," 2&# "#4#*-.+#,2 -$ 0 ,%# -$ !#** + *'%, ,!'#1 ,"#012 ,"',% 2&# $ !2-01 ," +#!& ,'1+1 2& 2
0#%3* 2# ," 2 0%#2 '1 -,# -$ 2&# +-12 '+.-02 ,2 - (#!2'4#1 ', 2&# 123"7 -$ &3+-0 * '++3,'27 "
# #! !"! $ ! #" ! # 30 0#!#,2 123"'#1 & 4# 7'#*"#" & #$
! & ! $-0 2 0%#2',% ', 5&'!& %#,-+# *--.',% .0-!#11#1 0',% 2 0%#2',% #*#+#,21
5'2& 2&#'0 -3," 20 ,1!0'.2'-, $ !2-01 1 2- 2&# 2 0%#2 *-!31 5�# 2 12 ** -* 2�# 7 #, *',%
!2'-, 302� -30 .0#*'+', 07 5-0) & 1 7'#*"#" ! # % " 2& 2 **-5 31 2- -4#0!-+#
- 12 !*#1 2& 2 & 4# 127+'#" .0-%0#11 ', 2&# $'#*" , 2&'1 .0-.-1 * 5# 2 )# "4 ,2 %# -$ 2# !-,!#.23 *
," 2#!&,'! * "4 ,!#1 2- .3013# -30 !#,20 * %- * 2&0-3%& 2&# $-**-5',% 25- '+1
( #' & # !" % % ## #"
#5 $ !2-01 ',4-*4#" ', 2 0%#2',% 0# ),-5, ," ,- 1 1!0##,1 & 4# ##, 0#.-02#"
302�+-0# 2&# 1 2& 2 '," 2- +#"' 2# 0# 3,),-5, # 5'** 31# ,-4#* .'" 11 7
$-0 !#** *',#1 2- .#0$-0+ ),-!)-32 ," !2'4 2'-, 1!0##,1 2- '"#,2'$7 $ !2-01 ,"
.0-6'+'27 * #*',% ," /3 ,2'2 2'4# .0-2#-+'!1 2- '"#,2'$7 $ !2-01 2& 2 11-!' 2# 5'2& !2'4#
#*#+#,21 !2-01 '"#,2'$'#" 5'** # 4 *'" 2#" ', +3*2'.*# &3+ , !#** *',# +-"#*1 ," ', +'!#
( #! # #!$# " #
! # !##$! # !" " #%# " 2 & 1 ,-2 .0#4'-31*7 ##,
.-11' *# 2- 11#11 2&# 0-*# -$ !#** #11#,2' * $ !2-01 ', 7 !-+ ',',% -30 ,#5 0#!'1'-, 11#11+#,2 -$
0%#2',% 11 7 5'2& "#%0-, 2#!&,-*-%7 5# 5'** 0'%-0-31*7 2#12 2&# 0-*# -$ !&0-+ 2', 0!&'2#!230 *
.0-2#',1 + (-0 !#** 1 ," $ !2-01 '"#,2'$'#" ', '+ $-0 2&#'0 0-*# ', !0-11 2&# #,2'0# %#,-+#
#!& ,'1+ -$ !2'-, 5'** # 11#11#" 2&0-3%& %#,-+# 5'"# 11 71 2& 2 11#11 . 0 +#2#01 -$ 20 ,1!0'.2'-,
#.'%#,#2'! + 0)1 $ !2-0 ',"',% ," !&0-+ 2', *--.',% #,-+# !2'4'27 + .1 5'** 0#4# * 2&#
!-,20' 32'-, -$ # !& $ !2-0 2- 2 0%#2',% 2 % ," ,-, % *-!' ', **7 5# 2 )# "4 ,2 %# -$ ,-4#*
0#!-,12'232'-, 1712#+ 2- 2#12 2&# &7.-2'1 2& 2 -3," 1 2 0%#2 31',% ',20',1'! **7
"'1-0"#0#" !2'4 2'-, "-+ ',1 2- !0# 2# .& 1# 1#. 0 2#" !-,"#,1 2#
-%#2� -30 .0-.-1#" 123"'#1 0# 1'%,'$'! ,2 $-0 2&# "#4#*-.+#,2 -$ ,#5 2#!&,-*-%'#1 ," $-0
3,"#012 ,"',% +#!& ,'1+1 -$ ,2' -"7 %#,# "'4#01'$'! 2'-, ," ! 31#1 -$ %#,-+# ',12 '*'27 ," ! ,!#0

Public health relevance
NARRATIVE The process of somatic hypermutation alters antibody genes and is critical for effective vaccine responses and for the production of antibodies that provide strong protection against infections. We will determine the mechanisms and proteins that allow the somatic hypermutation machinery to act efficiently on antibody genes and how these mechanisms and proteins determine which areas of the human genome are susceptible to genetic damage by this same machinery. These experiments will provide a better understanding of the mechanisms that allow for effective immune responses and of the causes of chromosomal aberrations that are the hallmarks of cancer, particularly B cell lymphomas and leukemias.